CRCNS: There and Back Again Linking Global Maps to First-Person Perspectives

The ability to seamlessly move between global map perspectives (GMPs), such as looking at a map or
taking in a scene from a high vantage point, and first-person perspectives (FPPs), such as being on the
ground immersed in the scene, has obvious importance for navigation and, more broadly, flexible
perspective-taking. Using a multidisciplinary approach, we will investigate the neural architectures,
environmental features, and spatial representations that support these transformations. We will develop
neural network models that make predictions to be tested in experiments with the rodent and human, and
use that experimental data to inform the model.

Public health relevance
The proposed work takes a multidisciplinary approach to studying the retrosplenial cortex and the subiculum, both of which are important for memory. The retrosplenial cortex is one of the first areas to be affected by Alzheimer’s disease, and topological disorientation is one of the first symptoms. Greater knowledge of retrosplenial cortex and subiculum function will help determine earlier identification of those at risk for these disorders.